Data Coordinating Core

Data Coordinating Core
SUMMARY
A key factor which has hindered research into TBI related neurodegeneration (TReND) is the narrow focus on
chronic traumatic encephalopathy (CTE) with far less consideration given to the broader group of
neuropathological effects of TBI. Indeed, most TReND research efforts involve a single, localized population
and are conducted at a single site; furthermore, the data derived is largely unavailable to the broader
community. As has been demonstrated in related neurodegenerative diseases such as Alzheimer’s and
Parkinson’s disease, broad, coordinated, and multi-institution efforts bolster the quality of research by drawing
data from multiple populations. To achieve this for the TBI research community, the CONNECT-TBI Data
Coordinating Core will focus its efforts on the establishing central, standardized, and reliable handling of all
data relating to the Research Projects. Through close interaction with the Administrative and Brain Bank Core,
a central repository of all neuropathological and clinical data will be made available to all authorized
investigators. This Core intends to implement the NINDS established sets of Common Data Elements (CDEs)
to characterize TBI at local sites and compile these data in the central database.